Development and assessment of an HIV disclosure intervention for men in Uganda

PROJECT SUMMARY
Background: In sub-Saharan Africa, men consistently lag behind women along each step of the HIV care
cascade and contribute to HIV transmission among women. Disclosure of HIV is a key step in prevention,
however, few evidence-based resources exist to support HIV disclosure among men with HIV (MWH) in sub-
Saharan Africa. Candidate: My long-term goal is to become an independent, NIH-funded clinical researcher
dedicated to interventions to support HIV and sexually transmitted infection (STI) prevention and treatment in
resource limited settings. Mentoring: Drs. Jessica Haberer (clinical trial implementation) and Lynn Matthews
(methods for intervention development; co-primary mentors) are both successful NIH-funded investigators who
have both mentored multiple NIH career development awardees. Drs. Winnie Muyindike (HIV clinical care
engagement and outcomes), Andrew Mujugira (male engagement in HIV and STI care and research), Christina
Psaros (behavioral science theory), Seth Kalichman (HIV disclosure and assisted partner notification), and
Bethany Hedt-Gauthier (advanced clinical trial analysis and biostatistics) will provide additional focused
mentorship to ensure success. Research: The goal of this proposal is to develop and test an HIV disclosure
intervention focused on MWH meeting the following eligibility criteria: with STI symptoms who are either not
accessing antiretroviral therapy or are accessing antiretroviral therapy but without viral suppression. In Aim 1, I
will identify the unique HIV disclosure needs and preferences to support HIV disclosure through in-depth
qualitative interviews with up to 30 MWH meeting eligibility criteria. In Aim 2, I will utilize the findings from Aim
1 to adapt interventions with HIV disclosure components in order to develop a novel HIV disclosure
intervention focused on MWH. The intervention will be iteratively refined through focus group discussions with
up to 20 participants, their sexual partners, and a community advisory board. In Aim 3, I will recruit 70 MWH
meeting eligibility criteria for participation in a randomized controlled trial to pilot test the intervention against an
attention-matched control group. Participants will be encouraged to bring their sexual partners for study
enrollment and HIV testing and counseling. Up to 15 MWH and their sexual partners will be invited for
qualitative interviews. I will measure the primary outcomes of acceptability and feasibility by mixed methods.
Training: To achieve my aims and gain research independence, I require additional training in: 1) behavioral
science theory for behavioral intervention development and assessment 2) methods for behavioral intervention
development, and 3) advanced behavioral clinical trial analysis. Based on my previous research experience
and success, support from an exceptional mentoring team, strong institutional commitment, and an innovative
research plan, I am well-positioned to become an independent clinical investigator focused on HIV and STI
prevention and treatment in resource limited settings.

Public health relevance
PROJECT NARRATIVE In sub-Saharan Africa, men consistently lag behind women along each step of the HIV care cascade and contribute to HIV transmission among women. HIV disclosure is a key step in HIV prevention, however, few evidence-based resources exist to support HIV disclosure among men with HIV in sub-Saharan Africa. I propose to develop and pilot test an HIV disclosure intervention to support men with HIV with STI symptoms who are either not accessing antiretroviral therapy or are accessing antiretroviral therapy but without viral suppression, with the goal of engaging men in care and decreasing partner HIV transmission.